Cannabis Research Analytics Core

PROJECT SUMMARY/ABSTRACT
CANNABIS RESEARCH ANALYTICS CORE
Scientific and public uncertainty exists regarding the health effects and harm of widely available cannabis
products and how these effects may vary across the lifespan. Some forms of cannabis (e.g., concentrates) have
substantially higher contents of tetrahydrocannabinol (THC) than those available in the past. Our knowledge
about cannabinoid pharmacokinetics, drug metabolism and drug-drug interaction is still surprisingly
incomplete, especially when it comes to the more recently introduced variety of available cannabis
products. One of the main problems is the difficulty to estimate the exposure to cannabinoids. This is a rapidly
growing clinical problem as legalization of cannabis for medicinal and recreational purposes progresses and
healthcare providers are increasingly confronted with cannabis use among their patients. In this context the
primary AIM of the Cannabis Research Analytics Core (CRAC) is the centralization of functions that are
common to all projects with the focus of systematic evaluation of cannabinoid exposure and associated
changes in endocannabinoid system (ECS) and connected pathways. The evaluation of the effects of
cannabinoids and other cannabis components (e.g., terpenes) on physiological processes and endogenous
biomarker homeostasis at different stages in life is essential for the accurate interpretation of the
pharmacodynamic properties of the components in cannabis. We propose to carry out the following 3 aims: AIM
1. Drug Exposure Assessment. Data gained from these cannabinoid and terpene analyses will give insights
regarding cannabinoid and terpene exposure and drug-drug interactions. CRAC will also generate a sample
repository. This will be the first biobank of its kind, focused on study of samples from cannabis users during
different stages in life. AIM 2. Biomarker Changes Assessment. Data gained from biomarker analyses will give
insights regarding cannabinoid associated pharmacodynamic changes in the endocannabinoid system, energy
metabolism (metabolomics) and the inflammatory status (lipidomics). These parameters constitute the basis for
differences in the benefits or harm of effects of cannabinoids across the lifespan of cannabis users. AIM 3.
Evaluation of Population Pharmacokinetics to Estimate Individual Exposure and Health Risks. CRAC will
address critical important gaps in clinical and scientific knowledge of cannabinoid exposures by developing and
validating methods to estimate an individual’s exposure to cannabinoids, using the sparse sampling data from
the proposed research projects in combination with published population pharmacokinetics (PK)/
pharmacodynamics (PD) modeling. The cannabinoid PK/PD models will evaluate the relationships between
cannabinoid exposure and health risks and possible benefits across the lifespan. Impact on the field: The
services of the CRAC will enable investigators to estimate cannabinoid exposure as well associated changes in
metabolic, physiological, and mental functions in cannabis users over their lifetime.